IGF::OT::IGF: ASSESSING RELATIONSHIPS BETWEEN ACCESS TO STANDARDIZED NUTRITIONAL CARE AND HEALTH OUTCOMES AND COST EFFECTIVENESS OF CARE IN OUTPATIENT CANCER CENTERS.

ASSESSING RELATIONSHIPS BETWEEN ACCESS TO STANDARDIZED NUTRITIONAL CARE AND HEALTH OUTCOMES AND COST EFFECTIVENESS OF CARE IN OUTPATIENT CANCER CENTERS.